Nuclear Localization and Function of the Ebola Virus VP40 Protein

Summary: Ebola (EBOV) and Marburg (MARV) are emerging zoonotic viruses that cause sporadic outbreaks
of both acute hemorrhagic fever and chronic persistent infections, from which they can re-emerge to cause long-
term sequelae or death. Filovirus-host interactions can be exploited as potential targets for the much-needed
development of novel antiviral countermeasures. As such, we have reported on modular interactions mediated
by filoviral PPxY Late (L) domain motifs conserved in EBOV/MARV VP40 matrix proteins and WW-domains of
select host proteins such as Nedd4, WWP1, WWOX, and BAG3. Recently, one of the more intriguing “hits” from
our screen of ~115 WW-domain containing host proteins using WT or mutant PPxY motifs from eVP40 and
mVP40 as bait was Yes-Associated Protein (YAP). YAP traffics into the nucleus where it functions as the key
downstream transcriptional effector of the Hippo signaling pathway; a pivotal pathway controlling organ
size/development, cell proliferation/migration, cellular homeostasis, and the induction of EMT (epithelial
mesenchymal transition); a process promoted by EBOV infection. Intriguingly, nuclear shuttling of YAP is
regulated in part by PPxY/WW-domain interactions mediated by the PPxY motifs within the LATS1/2 kinases
that are identical to those of eVP40 and mVP40. We and others have noted detectable levels of EBOV VP40 in
the nuclei of both VP40-transfected and live EBOV infected cells, including Huh7, Hela, HUVEC and monocyte-
derived macrophages (MDMs). Viral/host proteins that lack a nuclear localization signal (NLS) can interact with
another protein to hitch a ride into the nucleus via a broad strategy known as “nuclear hitchhiking”. Based on
these findings, the lack of an NLS on eVP40, and our surprising findings linking EBOV infection and eVP40 with
YAP, we hypothesize that eVP40 hitchhikes into the nucleus with YAP as the driver. Moreover, as YAP-bound
host proteins (e.g. angiomotin {Amot}) that enter the nucleus can skew YAP-mediated transcriptional
programming, we hypothesize that and once in the nucleus, eVP40 impacts YAP-mediated transcription to
promote the establishment of a cellular environment conducive for a productive infection and efficient virus
dissemination. We will address each aspect of our hypotheses in two Aims. In Aim 1, we will test our hypothesis
that eVP40 hitches a ride into the nucleus with YAP in a PPxY/WW-domain dependent manner and in Aim 2,
we will investigate the biological significance of nuclear eVP40 by determining whether a nuclear eVP40-YAP
interaction skews YAP-dependent transcription patterns to those that might favor EBOV production and
dissemination. We believe that this project fits well with the R21 format, as our Aims originate from a firm scientific
premise, while also being exploratory in nature. Indeed, identification of a biologically relevant VP40 nuclear
phase of EBOV infection could potentially open new and exciting areas of investigation into EBOV-nuclear
interactions, EBOV pathogenesis, and novel antiviral targets/strategies.

Public health relevance
Narrative: We and others have detected EBOV VP40 in the nucleus of transfected and live EBOV infected cells. Here we will investigate the mechanism by which EBOV VP40 enters the nucleus and determine whether nuclear import of VP40 requires a host chaperone. We will also determine whether nuclear VP40 can modulate host gene expression to establish a cellular environment conducive for virus replication and spread. By investigating this novel cellular localization of VP40 and its host interactions, we may uncover new targets and strategies for the development of novel antiviral therapies.